Micron-scale Spatial Metagenomic Mapping of Microbial Biogeography in the Gastrointestinal Tract

PROJECT SUMMARY
The commensal microbiome of the human gastrointestinal (GI) tract plays a critical role in host metabolism,
immunity, and homeostasis. Dysbiosis of the gut microbiome is often associated with a loss in species diversity,
which can lead to increased susceptibility to metabolic dysregulation and higher chances for pathogens to
proliferate unhindered. For instance, Clostridioides difficile infections (CDI) is an archetypical bacterial infection
of the GI tract and a leading cause of hospital-acquired infections with severe negative outcomes including death.
Current treatment of CDI includes the use of fecal microbiota transplantation (FMT), which aims to restore the
disrupted gut milieu with a health microbiome. Unfortunately, the mechanism of such therapies is not well
understood as the rules governing microbial colonization of the GI tract have not been determined. We have
been developing spatial metagenomics as a unique and versatile approach to delineate the micron-scale spatial
organization of microbes in the gut that we hypothesize to play a major role in gut microbiome ecology. Here in
this renewal application, we propose 3 specific aims to 1) expand current techniques for spatial metagenomics
by adopting new approaches in single-cell genomics to increase throughput and enable new capabilities for
whole-genome analysis of the gut microbiome, 2) apply spatial metagenomics to human and mouse fecal
samples to delineate the process of microbiome recovery after fecal microbiome transplantation, and 3) leverage
our unique robotic culturomics system to isolate undiscovered strains in the gut and identify interspecies
interactions that drive community assemblage. These proposed studies constitute an exciting and concerted
push toward spatial profiling of the human gut microbiome in healthy and diseased states. Through a combination
of innovative conceptual and technical advances enabled by our approach, this effort will create new avenues to
mechanistically explore the role of the gut microbiome in health and disease.

Public health relevance
RELEVANCE Understanding the spatial organization of the gut microbiome can reveal crucial insights for its composition, stability, and resiliency, and improve our knowledge of its essential roles in digestion, metabolism, and immunity. This proposal aims to develop and apply new technologies for spatial metagenomics to dissect the micron-scale structure of the gut microbiome in mice models and in healthy and dysbiotic human cohorts. Findings from this study will have direct relevance for deciphering the principles governing microbial colonization of the gastrointestinal tract, which can help guide the development of clinical treatments using microbiome-based therapies.